A multiscale computational tool to simulate the PK of orally-administered drugs in the human GI tract

A multiscale computational tool to simulate the PK of orally-administered drugs in the human GI tract Project Summary/Abstract: Most FDA approved drugs are administered orally, despite the complex process of oral drug absorption that is difficult to analyze experimentally. Oral bioavailability is dependent on the interplay between multiple and simultaneous processes that are dependent on both the drug compound as well as the physiological and anatomical states of the user. Due to this complexity, computational models have emerged as a tool to integrate these factors in an attempt to mechanistically capture and predict the process of oral absorption in a robust and accurate manner. The current predictive models are generally 0D compartmental models and are thus limited by simplified physiological characteristics of the gastrointestinal tract (GIT), by semi-empirical or specific analytical solutions of dissolution profiles, and by insufficient descriptions of interactions between delivery vehicles and the GIT. In particular, the absorption can be incorrectly modelled using the 0D models for (i) some drug classes (under the BCS scheme), (ii) for GIT, whose sizes are significantly different from the median human and (iii) for drugs, that are meant to target specific regions (for instance, the drugs used to treat some colon cancer) by incorrectly predicting the absorption in other regions. In this project, we propose to develop an efficient and spatially accurate computational tool to simulate the dissolution, transport, Liberation, Absorption, Distribution, Metabolism, Elimination, and Toxicity (LADME-T) of orally administered drugs in the human GIT at the enzyme, delivery-vehicle, intestine-tissue, and GIT levels. This will be further combined with the compartmental model at the whole-body level to predict systemic pharmacokinetics. In Phase I, the multi- scale computational tool will be constructed by integrating the spatially accurate first-principles driven high- fidelity drug transport, dissolution and absorption model in the human stomach and GIT, mechanistic drug release models, and the multi-layer intestine physiologically-based pharmacokinetics (lumen, enterocyte, and blood layers) models. These will be accomplished using the recently demonstrated CFD Research Corporation’s spatially accurate Q3D framework. In Phase II, we will (i) test and validate the models for drug transport and absorption physics for the 4 BCS classes of drugs, (ii) morph the GIT to create variants corresponding to diseased specimens and different anatomical sizes, (iii) perform and validate the spatially accurate drug absorption simulations for these new GIT variants, (iv) obtain the PK parameters and perform the drug absorption simulations for infants and children, (v) link the Q3D GUT model to the whole body PK model, and (vi) use this multiscale model, to optimize specific cases, including the drug delivery to target regions. The multiscale software developed in this project will provide a powerful virtual platform in investigating LADME-T, facilitating in vitro-in vivo scaling, designing and developing targeted oral drug delivery systems, and evaluating safety and efficacy of oral drug products. Ultimately, the proposed tool will be developed into a commercial product to meet urgent demands from pharmaceutical and biomedical industries.

Public health relevance
Project Narrative: The novel software tool proposed in this project will provide an efficient and spatio-temporally accurate multiscale computational platform to virtually test, design, and develop oral drug products. This will be achieved by investigating interactions between drug delivery systems and the human physiological systems from enzyme levels to whole-body levels, and by revealing key aspects affecting oral drug absorption and consequent therapeutic or toxic effects. The developed tool will meet urgent demands from pharmaceutical and biomedical industries by accelerating drug discovery and development processes, by facilitating translational applications from bench to bedside, by increasing success rates of new drug products, and by ultimately helping reduce the health care burdens on society.